SWG: HIV and Aging

Project Summary/Abstract
The overall objectives of the San Diego Center for AIDS Research (SD CFAR) Scientific Working
Group (SWG) Program are to: a) identify promising new areas of HIV research through our strategic
planning process, b) develop research expertise and capacity in these areas, and c) coordinate
education and new collaborations across SD CFAR institutions and with the HIV community. We
designed our SWG Program to be flexible to respond to new opportunities as they arise. This flexibility
is critical since we plan to adopt 2-3 new SWG topics during the proposed 5-year funding cycle. Topics
will reflect NIH Office of AIDS Research (OAR) priorities and local resources and expertise. We
propose to first focus on HIV & Aging, a topic that was chosen by our membership through our
strategic planning process because we have considerable resources and expertise in this area that
could be strengthened by identifying synergies and creating collaborations. While SD CFAR institutions
have multiple successful programs that focus on either HIV or aging, there efforts have not yet been
combined to investigate aging-related issues in people living with HIV. We propose to organize the
work of the SWG into three aims.
Aim 1 will focus on engaging and networking scientists in HIV and Aging-related fields to identify
opportunities for collaboration and new research. Targeted disciplines will include Geriatrics, Biological
Aging, Genomics, and Microbiome Science.
Aim 2 will strengthen these connections by disseminating new research findings on HIV & Aging via a
seminar series and other methods and by coordinating mentoring of junior investigators toward
independence.
Aim 3 will focus on building the research program to self-sustainability, monitoring progress, and
strategic planning to identify the next SWG topic.
We anticipate that success in these aims will foster new collaborations among scientists from different
disciplines and backgrounds. To support these aims, we have recruited two new investigators to lead
the SWG, one experienced in HIV & Aging translational science (Scott Letendre, M.D., UCSD) and the
other experienced in basic science (Scott Peterson, Ph.D., Sanford Burnham Prebys Medical Research
Institute). Drs. Letendre and Peterson have worked together on gut microbiome research and
mentoring of junior investigators and are well suited to lead the SWG moving forward.